Structural and functional analysis of human chromatin re

The ATP-dependent chromatin-remodeling complex, Rsc, was originally identified in yeast. It has a subunit composition similar to the well-characterized SWI/SNF: 2 subunits are shared between the two complexes and at least 4 others are homologous. However, the function of Rsc is distinct from SWI/SNF. Rsc is essential for the mitotic growth of yeast, whereas SWI/SNF is not. Rsc mutants are arrested at the G2/M transition during the cell cycle, and the arrest is dependent on spindle-checkpoint genes. The mutants are also more sensitive to microtubule- destabilizing drugs. These data suggest that Rsc may play a role in mitosis, perhaps by stabilizing mitotic spindle formation or have a function at kinetochores. We have previously purified several ATP-dependent chromatin remodeling complexes from human that are closely related to either yeast SWI/SNF or Rsc. By microsequencing and cloning, we now identified the BAF180 subunit of human SWI/SNF-B complex as a human homologue of yeast Rsc subunits, Rsc1, Rsc2 and Rsc4. It has the same set of biochemical motifs as the three Rsc subunits: 6 bromodomains, 2 BAH regions, and a minor-groove binding domain. Database search of the completed genome database of human, Drosophila and C.elegans showed that BAF180 is the closest homolog of the three Rsc subunits, suggesting human SWI/SNF-B as a human version of Rsc. We renamed this complex as PBAF (for Polybromo-associated BAF complex). We subsequently identified many other subunits of human PBAF complex and found a number of them to be identical to those in human SWI/SNF. We also demonstrated that BAF180 localizes at kinetochores of mitotic chromosomes, consistent with a function for PBAF during mitosis. Part of this work has been published in Proc. Natl. Acad. Sci. USA in 2000. As a continuation of this project, we have identified three possible new components of this complex. We have obtained antibody against one of them, BAF200. With this antibody, we have been able to show that BAF200 is indeed an intrinsic component of this complex. [unreadable] In a paper published in 2005 in Genes and Development, We provided in vivo evidence that PBAF and BAF selectively regulate expression of distinct interferon-responsive genes: PBAF is required for expression of IFGM1, whereas BAF is required for IFGM3. Because PBAF and BAF share 8 identical subunits, the unique subunits that distinguish the two complexes must play a key role in selectively targeting each complex to their respective genes. We showed that between the two unique subunits of PBAF, BAF180 and BAF200, only the latter is required for expression of IFGM1. Our study demonstrated the importance of BAF200 in PBAF functions, and suggested that BAF200 likely serves as a targeting subunit for PBAF. [unreadable] [unreadable] We are now investigating the underlying mechanism of how BAF200 targets PBAF to its target genes. As a first step, we identified a cell line that lacks BAF200. We were able to re-introduce exogenous BAF200 into this cell line, and reactivate the PBAF complex. Using these two lines, we have performed cDNA microarray analysis and identifed many genes whose expression were either up-regulated or down-regulated by re-introduction of BAF200. We confirmed the microarray data by RT-PCR. We are investigating several candidate genes and determine how they are regulated by PBAF.